Chemical Toxicology Division Symposium

Project Summary The goal of this application is to obtain support for the American Chemical Society (ACS) Division of Chemical Toxicology (TOXI) 2020 national meeting program, which will be held August 16-20, 2020, in San Francisco, CA. The mission of the Division of Chemical Toxicology is to improve human health and public welfare by promoting the understanding of chemical mechanisms that govern disease processes and the toxicity of drugs, environmental agents, and endogenous chemicals. The theme for the ACS National Meeting is “Moving Chemistry from Bench to Market” and TOXI programming is well aligned with this theme. The TOXI programming will focus on the molecular mechanisms of environmental stress responses. The goals of the TOXI division include providing a forum for communicating research in chemical toxicology, encouraging research in chemical mechanisms of toxicity, and facilitating connections with other groups in scientific areas of mutual interest, as well as leadership and professional development of scientists at all levels. Thus, the requested funds will be used to support travel awards and expenses for graduate students, postdoctoral scholars, and junior faculty. The overall program is organized around the theme of molecular mechanisms of environmental stress responses. The program includes four thematic symposia, which will feature invited oral presentations by a diverse group of established and emerging investigators with a range of perspectives on each topic. The four thematic symposia are: (1) “Genome-wide Perspectives on the Formation, Repair, and Consequences of DNA Damage,” which will examine how toxicant-induced DNA adducts lead to specific mutations in cells; (2) “Metabolism of Fluorinated Compounds & Safety Relevance,” co-promoted with the with Divisions of Medicinal Chemistry and Fluorine Chemistry, will focus on toxicity that can result from metabolism of fluorinated compounds, which are widespread in the environment and comprise a large number of newly-approved drugs; (3) “Chemical Exposures and Impact on Health” focuses on neurotoxicology of environmental agents; and (4) “Toxicology of Antibody-Drug Conjugates,” co- promoted with the Divisions of Medicinal Chemistry and Biological Chemistry, focuses on the mechanisms and mitigation of dose-limiting toxicity of antibody-drug conjugates. The scientific program is clearly aligned with the mission of NIEHS of discovering “how the environment affects people in order to promote healthier lives.”

Public health relevance
Narrative The mission of the American Chemical Society (ACS) Division of Chemical Toxicology (TOXI) is to improve human health and public welfare by promoting the understanding of chemical mechanisms that govern disease processes and the toxicity of environmental agents, drugs, and endogenous chemicals. The goal of this application is to support the TOXI scientific program at the ACS national meeting, including sessions that focus on mechanisms by which environmental agents cause toxicity. The conference is an opportunity to disseminate recent results and for collaboration among environmental health scientists; therefore, this conference program is aligned with the health mission of NIEHS and NIH.